Core Support for Cancer Center

Cervical, anal, and oropharyngeal cancers are causally associated with high ?-HPV, particularly HPV16. The risks of these cancers are increased several-fold in persons living with HIV (PLWH) despite the widespread use of cART, and these risks increase further with diminishing CD4 count. Recently, a prospective nested case-control study by our research group (JAMA Oncol, 2016) found that not only HPV16 - but also certain β-/γ-HPV types - were strongly (independently) associated with incident head and neck squamous cell cancer (HNSCC). The odds ratios (ORs) ranged from OR=2.5 to OR=7.4 depending on the β-/γ-HPV type. Moreover, while HPV16 was only associated with tumors of the oropharynx, the β-/γ-HPV were prospectively associated with the incident development of tumors of the larynx, hypopharynx, oral cavity, as well as the oropharynx. In fact, β-/γ-HPV had a highly significant, independent association with oropharyngeal tumors even in those who tested positive for HPV16. β-/γ-HPV have known associations with skin cancer (SC) in patients with epidermodysplasia veruciformis, and are increasingly thought to play a role SC in general. SC incidence is highly elevated in PLWH and transplant patients (relative to the general population), consistent with an infectious cause. However, the role of β-/γ-HPV in cancer is thought to be distinct from that of HR α-HPV. While HR α-HPV are a necessary cause of cervical precancer/cancer, it is likely that β-/γ-HPV are more akin to a carcinogen. Whereas HR α-HPV are found integrated or episomal in tumor cells, β-/γ-HPV are transient and cannot reliably be detected in tumors. Nonetheless, β-/γ-HPV are common, including in the oral cavity, cervicovaginal and anal specimens, and β-/γ-HPV prevalence increases with HIV and low CD4. To our knowledge, however, there have been no longitudinal studies to understand the natural history of cervical β-/γ-HPV in HIV[+] or HIV[-] women. More importantly, there have been no prospective studies of β-/γ-HPV and subsequent cervical pre-cancer/cancer. Prospective/longitudial studies are essential since, as mentioned, β-/γ HPV are transient and the virus may not be concurrent with cervical disease. We therefore propose studying β-/γ-HPV natural history and it’s relation with cervical precancer/cancer in the Women’s Interagency HIV Study (WIHS). Few if any other cohorts have the needed long-term follow-up with q6mo gynecological exams, Pap testing and colposcopy/biopsy (when indicated).

Public health relevance
PROJECT NARRATIVE – OVERALL The Albert Einstein Cancer Center (AECC) seeks to reduce the burden of cancer through its basic, clinical, and population based research and the translation of preclinical and epidemiological studies into clinical initiatives for the prevention and treatment of cancer. This is accomplished through AECC's five established research programs and twelve shared resources. With its clinical partner, the Montefiore Health System, and its community outreach and engagement capabilities, AECC seeks to understand the basis for, and ameliorate, cancer disparities that affect the 1.4M, largely minority, population of the Bronx, the Center's catchment area.